Biomolecular simulation for the end-stage refinement of nucleic acid structure

Project Summary / Abstract
Despite significant advances in the performance and reliability of biomolecular simulation approaches, non-
helical nucleic acid structures are proving difficult to fully and accurately model with currently available
biomolecular force fields. This research aims to assess, validate, and improve force fields for nucleic acids, and
also to better understand the true conformational ensemble of model DNA and RNA systems by best fits to NMR
experiment using Maximum Entropy methods. This includes characterization of not only the dominant
conformations, but also excited states or low population states. Model systems include RNA dinucleotides, RNA
tetranucleotides, RNA tetraloops, DNA mini-dumbbells, and NMR-derived NMR structures that are known to
populate multiple structures or excited states. Methods employed include state-of-the-art multi-dimensional
replica-exchange molecular dynamics (M-REMD) simulations and various NMR approaches to provide more
insight into new tetranucleotides both in structure (NOE, J-coupling, etc.) and for excited states via NMR
relaxation and NMR relaxation dispersion experiments. The M-REMD code will be extended to allow
asynchronous ensemble instances (for greater efficiency and queue backfill) and adaptivity and steering with
on-the-fly analyses to assess convergence and where more/fewer ensemble instances are needed. Various
approaches to force field improvement include surrogate methods for re-weighting converged MD trajectory
ensembles and project free energy surfaces with Multistate Bennett Acceptance Ratio methods as a function of
force field parameter change, where possible, via parameter scanning, via fits to high level base-base interaction
energies from high level QM, and small model compound fits to liquid densities and other methods. In addition,
the group will work with the Open Force Field Initiative to adapt, assess, and validate their small molecule force
fields to nucleic acids. Using M-REMD methods the team has proven the ability to fully sample the conformational
ensemble of the proposed model systems with large-scale computation on GPUs with multiple different force
fields. The group has considerable experience in large-scale simulation of DNA and RNA and a proven track
record of collaboration and dissemination of research findings and results. Development of better methods for
simulation of the structure, dynamics and interactions of nucleic acids provides the means to approach drug-
ability and the design of novel therapeutics, and also to provide greater insight into the role of structure, dynamics
and conformational change in function which at a basic science level provides unique capabilities that could have
considerable health relevance if the methods are made to function correctly and accurately.

Public health relevance
Project Narrative By assessing, validating and improving biomolecular simulations approaches and their accuracy towards modeling nucleic acids, we can gain greater insight into nucleic acid structure, dynamics, function, and interactions with other biomolecules. Ultimately such approaches could be applied to better understand how to modulate function, understand biological processes mediated by nucleic acids, and provide for better capabilities for the design of drugs to target nucleic acids. For example, such approaches could provide new insight into anti- viral therapeutics, riboswitches, and greater insight into health related processes involving nucleic acids at the atomistic level.